Functions of chromatin remodeler Chd7 in retinal cell development

CHD7 (Chromodomain helicase DNA-binding 7) is an ATP-dependent chromatin
remodeling protein that has critical functions in neurogenesis and neural crest cell
development. Pathogenic variants in CHD7 are the most common cause of CHARGE
syndrome or CHD7 disorder, a complex genetic syndrome characterized by ocular
coloboma, heart abnormalities, choanal atresia, retardation of growth, genitourinary
defects, and hearing loss, as well as other developmental defects. Although some
studies have examined the molecular basis for the early ocular defects (such as
coloboma) resulting from CHD7 pathogenic variants, it is not known whether there is a
continuing requirement for CHD7 in the developing retina once ocular morphogenesis is
complete. We have recently shown that CHD7 is robustly expressed in subsets of newly
differentiated retinal cell types, including rod and cone photoreceptors, as well as in
proliferating retinal progenitor cells. Furthermore, zebrafish and mouse Chd7 mutants
display reductions in cone photoreceptor number and abnormally small photoreceptor
outer segments, suggesting a critical role for CHD7 in photoreceptor differentiation and
outer segment morphogenesis. We hypothesize that the chromatin remodeling function
of CHD7 is necessary for the transcriptional activation of genes promoting retinal cell
type differentiation and genes involved in photoreceptor outer segment morphogenesis.
In this proposal, we will test this hypothesis through a combination of zebrafish and
mouse genetics, transcriptomic and epigenomic analyses, and studies of human retinal
organoids and human retinal imaging. Results from these studies will contribute to our
understanding of the genetic and epigenetic regulation of retinal cell type development
as well as the pathogenesis of visual system defects associated with CHD7 disorder.

Public health relevance
Disruptions to the process of eye formation can result in ocular birth defects and pediatric blindness; although some of the genetic causes of ocular birth defects have been identified, we still don’t have a good understanding of exactly how mutations in these genes cause visual system dysfunction. In this grant proposal we will study the function of the chromatin remodeling factor CHD7 during eye development; these studies are important because loss of expression of CHD7 causes CHARGE syndrome (also known as CHD7 disorder), a genetic disorder that results in defects in the eyes, ears, heart, brain, nose, and genitourinary system. The results of our experiments will help us better understand the chain of events that leads to abnormal eye formation during embryonic development, and this knowledge may improve the identification, management, and treatment of congenital sight-threatening diseases.